METABOLIC EFFECTS OF TESTOSTERONE IN MAN

To assess the dose dependent effects of testosterone on protein, glucose and lipid metabolism as measured by leucine and glucose turnover and plasma lipoprotein profile in hypogonadal man.